Relapse after Discontinuation of Antipsychotics during Pregnancy (R-DAP study)

Project Summary
There is an increase in psychotropic medication use in women in their fertile ages. Due to concerns for the
developing fetus, half of women decide to discontinue their medication before- or at the beginning of pregnancy.
While the wish to avoid in utero medication exposure to the fetus is understandable, discontinuation of medication
might lead to relapse, which can have a profound negative impact on the health of mother and child. In our prior
R01, we showed that relapse risks were relatively limited for women with unipolar depression who chose to
discontinue their antidepressant medication before or during pregnancy. In addition, we found limited risks for
those women who choose to continue their antidepressants as we found a small increase in the risk of short-
term but not long-term outcomes associated with antidepressant exposure for offspring. While our findings
greatly help in weighting risks and benefits for women with unipolar disorders, there is an urgent need to
investigate risks in women with bipolar disorders, given that these women are at very well high risk of severe
relapse in the perinatal period which can lead to suicide or infanticide. Currently, antipsychotic medication (AP)
is the most used treatment option in bipolar patients during the perinatal period but data on the efficacy of AP in
preventing perinatal relapse is completely lacking. Moreover, both short- and long-term effects of AP on maternal
and offspring health are insufficiently known. In this renewal, we propose to investigate the risks and benefits of
antipsychotic use during pregnancy for women with bipolar disorder and their offspring. We will use large and
comprehensive Danish and Swedish population-based registers and with this sample size, we will be able to
investigate efficacy of Antipsychotics (AP) in prevention of relapse in bipolar women the perinatal period (aim
1); we will investigate adverse short and long term maternal health outcomes of both relapse and/or AP use (aim
2). In our last aim we will determine the long-term effects (up to 24 years) of maternal relapse during pregnancy
and the postpartum period on the offspring and the effects of in utero AP exposure on the offspring (aim 3).
.

Public health relevance
Project Narrative Approximately 50% of women with bipolar disorder discontinue their antipsychotic medication during pregnancy due to concerns for the fetus but this approach might put these women at high risk for relapse, which can have severe consequences. The proposed studies will investigate the risks and benefits of antipsychotic use during pregnancy using large and comprehensive Danish and Swedish population-based registers and will help to answer whether continuation or discontinuation of antipsychotics will present the least risk to both mothers and their offspring.